EFFECTS OF GEMFIBROZIL, SIMVASTATIN, AND ATORVASTATIN IN TYPE III HYPERLIPIDEMIA

This study will compare the hypolipidemic effects and influence of lipoprotein and cholesterol metabolism of gemfibrozil, simvastatin and atorvastatin in patients with type III hyperlipidemia. After a 4 week dietary baseline, patients will be treated in a random sequence with gemfibrozil (1,200 mg/day), simvastatin (40 mg/day) or atorvastatin (10 mg/day or 80 mg/day) each for 8 weeks; efficacy, metabolic effects and safety will be evaluated on each regimen.